Closed-loop laryngeal pacing for voice restoration

Project Summary and Abstract The most common neurogenic voice disorder is unilateral
vocal fold paralysis (UVFP), which can substantially reduce quality of life. Current available
surgical treatments offer only temporary improvement in voice through placement of resorbable
materials or involve permanent, invasive alteration of the larynx that incompletely restores voice
and often requires revision surgeries. There is limited access to advanced surgical procedures
with moderately better outcomes due to the need for specialized surgical techniques and an
increased risk of invasive procedures.
Functional electrical stimulation (FES) has the potential to restore dynamic vocal fold (VF)
closure (adduction), improving voice and airway protective outcomes for the UVFP patient
population. Laryngeal electromyography (LEMG) studies have shown that about 85% of those
with chronic UVFP do not have complete VF denervation, opening the door to low-intensity
closed-loop FES to reanimate paralyzed VFs. Several studies have indeed shown that
laryngeal muscles with synkinetic reinnervation can be effectively stimulated or “paced” to
restore dynamic VF opening (abduction). However, laryngeal pacing devices to date have only
stimulated VF abduction to facilitate breathing and have only used preset patterns of stimulation
(open-loop control) rather than sensing and responding to the physiological needs of the
individual (closed-loop control). Herein we describe a novel closed-loop laryngeal FES system
for reanimation of VF closure (adduction) to treat UVFP. The proposed system builds upon
proven approaches for implant devices and FES, yet includes multiple key innovative elements,
and will create an entirely new medical device tailored for reanimation of paralyzed VF
adduction to support voice and airway protection.

Public health relevance
Narrative Due to the complexity of stimulation requirements and the need to isolate co-located but functionally distinct muscle groups in the larynx, there has been minimal progress towards a medical device that can restore the ability to communicate after vocal fold paralysis. Recent research advances at Massachusetts General Hospital in canine models have demonstrated a path that allows independent and graded control of muscle activation. This project seeks to de-risk future development of a fully implantable system for human testing in a future Phase II STTR project by developing a chronically placed electrode that meets the requirements of the severely space- constrained structure while maintaining implant longevity.